Social and structural violence and HIV care continuum outcomes: Developing a trauma-informed HIV care intervention among WLWH

PROJECT SUMMARY/ABSTRACT
We will use innovative social epidemiological methods to longitudinally characterize the impacts and
mechanisms of gender-based violence on the HIV care continuum, define key components of differentiated
HIV care models that mitigate these relationships and develop a platform for trauma- and violence-informed
HIV care and practice (TVI-HCP) interventions, among cisgender (cis) and transgender (trans) women living
with HIV (WLWH). Emerging evidence suggests that the COVID-19 pandemic has resulted in heightened
social and structural gender-based violence against cis and trans women, who are shouldering an inequitable
share of the resulting impact of restrictions, physical distancing and economic downtown. Impacts felt by
marginalized cis and trans women, including WLWH, are even more severe and the short- and long-term
consequences in terms of trauma, violence, safety and HIV care continuum outcomes of cis and trans WLWH
will need to be addressed. Even prior to COVID-19 crisis, despite substantial programmatic advancements,
WLWH experienced gaps relative to cisgender men in all global HIV targets in many settings. Although the
global prevalence of social and structural violence by WLWH is alarmingly high, there is a lack of research
delineating mechanisms through which different types of violence impact HIV care continuum outcomes, to
inform intervention targets. Moreover, despite calls to apply a trauma-and violence-informed care approach to
HIV care and practice (TVI-HCP) and the unique needs of WLWH, surprisingly little is known about how this
approach can be tailored in HIV clinical practice environments. In the proposed study we will leverage an
existing community-based cohort of cis and trans WLWH in a Canadian setting (Sexual Health and HIV/AIDS:
Women's Longitudinal Needs Assessment) and recapture and expand this cohort to 300 WLWH in the City of
Vancouver. This quantitative study will include survey interviews, innovative mapping and spatial analyses, HIV
disease monitoring, and confidential administrative linkages to fill critical research gaps and inform
components of multi-level TVI-HCP programming to optimize HIV care continuum outcomes by: (1)
Prospectively characterizing relationships between different types of violence experiences (interpersonal
emotional, physical and sexual violence; neighbourhood violence) and viral load suppression failure and
identifying critical mediators in these relationships on which to intervene; (2) Prospectively characterizing the
key components of differentiated HIV care models that have the strongest associations with viral load
suppression, expanding on our preliminary development and validation of a TVI-HCP Scale for WLWH; and (3)
Establishing an innovative social epidemiological platform for informing and evaluating future multi-level
trauma- and violence-informed HIV care interventions. Amidst the ongoing COVID-19 crisis, in parallel with a
syndemic of violence, trauma and HIV in North America, our study offers an unprecedented opportunity to
inform differentiated HIV care models to optimize HIV clinical outcomes among marginalized women.

Public health relevance
PROJECT NARRATIVE Despite alarmingly high prevalence of gender-based violence experienced by women living with HIV (WLWH), and evidence suggesting that women are falling behind men in all HIV continuum of care outcomes in many US and other high-income settings, there remains a lack of research to mitigate and address the role of violence on HIV clinical outcomes. The need to develop innovative trauma- and violence-informed approaches that can be tailored to HIV care and the unique needs of WLWH to optimize HIV clinical outcomes has taken on a new urgency and significance in the wake of the COVID-19 crisis. The goal of the proposed study is therefore to use innovative methods to characterize the complex relationships between gender-based violence and HIV clinical outcomes, define key components of differentiated HIV care models that mitigate these relationships, and provide important implications for informing and developing future trauma- and violence- informed HIV care and practice interventions for WLWH.